Social and Behavioral Determinants of Health in High-Risk Veterans

Background. Social factors exert a substantially more potent impact on health than does health care, especially
among disadvantaged populations such as VA users. Adverse social determinants of health (SDH)—factors such
as housing instability, food insecurity, social isolation, and transportation barriers—are linked to problems with
access, poorer clinical outcomes, and increased health care costs. Despite the clinical and business case for
integrating SDHs into health care, these factors are not systematically assessed or addressed in clinical settings.
Significance/Impact. This study will leverage a previous survey of Veterans at high-risk for hospitalization, and a
new survey to be fielded to a nationally-representative sample of Veterans, to determine how SDHs influence
clinical, health care utilization, and experience outcomes. Review of findings by key stakeholders will generate
recommended SDH measures for universal screening within VA. These steps, coupled with qualitative interviews
about implementation challenges, will inform the future integration of high-value patient-reported SDH measures
into VA’s health record.
Innovation. The proposed work is innovative in its evaluation of a broad array of SDHs in high-need Veterans
to identify candidate measures for electronic health record (EHR) integration. The study will leverage a
theoretically-driven survey of SDH measures with a data-driven approach to identifying the associations between
these SDHs and a range of health, utilization, and patient experience outcomes. Results from these analyses
will inform a facilitated deliberative process to prioritize high-value, validated, and actionable measures that are
predictive of outcomes that are important to Veterans and the VA.
Specific Aims. In Aim 1, we will use data from an Office of Primary Care-funded survey of Veterans at high-risk
for hospitalization to examine relationships between patient-reported SDH measures and utilization, cost, and days
in the community outcomes. In Aim 2, we will field a survey to a nationally-representative sample of VA patients to
determine the association between SDH measures and key outcomes, and to examine the prevalence of SDHs in
subpopulations of Veterans who are disproportionately affected by disparities (e.g., women, racial/ethnic minorities,
and rural Veterans). Aims 1 and 2 will inform partner and stakeholder discussions in Aim 3 to identify measures
that are associated with key outcomes and that are perceived by operations partners as actionable (i.e.,
addressable through VA or community services) and thereby good candidates for EHR integration.
Methodology. In Aim 1, we will leverage data from an operations-funded survey that our team administered in
2018. Using survey data for 4,685 Veterans at high-risk for hospitalization, we will examine the association
between patient-reported SDHs and utilization (i.e., VA and Medicare emergency department visits and
hospitalizations), VA and Medicare costs, and days in the community. In Aim 2, we will field a similar survey to
a nationally-representative sample of Veterans, evaluate the association between SDHs, patient experiences
(e.g., perceived access and coordination), and 12-month VA emergency department visits, hospitalizations, and
costs, and describe the prevalence of SDHs in the general VA population and Veterans who are at risk for health
disparities. In Aim 3, we will use a facilitated deliberative process with key stakeholders to prioritize actionable
SDH measures for EHR integration, and then conduct qualitative interviews with health system leaders,
clinicians, staff, and patients to examine implementation barriers and facilitators to assessing select SDH
measures at point of care.
Implementation/Next Steps. This study addresses health equity, particularly relevant in light of COVID-19, and
will be conducted with partners from VA’s Offices of Primary Care, Health Equity, Rural Health, and Women’s
Health. The study is especially timely with VA’s transition to the new Cerner EHR as the proposed aims will identify
SDH measures for potential EHR integration that are concise, actionable, and predictive of important outcomes.

Public health relevance
There is increasing recognition that social determinants of health (SDHs)–personal circumstances and environmental factors that shape an individual’s daily life–contribute to meaningful variation in clinical and economic outcomes. Systematic procedures for assessing and addressing SDHs in health care settings could improve prevention and treatment efforts. In order for the Veterans Affairs (VA) system to achieve this goal, there is a need to evaluate the impact of SDHs in Veterans to determine the best candidates for integration into the electronic health record. The proposed study will leverage national surveys of the general VA population and Veterans at high-risk for hospitalization to identify SDH factors associated with health care utilization, cost, community bed days, and patient experience outcomes. We will partner with VA leadership, clinicians, patients, and caregivers, to prioritize SDHs that are actionable (i.e., addressable through VA or community services) and develop recommendations for SDH measure screening procedures and electronic health record integration.